Alpha- to Beta-Cell Communication in Health and Disease

Summary of Work
Glucagon is canonically viewed as an essential counterregulatory hormone that prevents hypoglycemia by driving
endogenous glucose production (EGP) in the liver. We and others have revealed additional roles for glucagon
that emphasize a much more complex control of metabolism beyond hypoglycemia. On such role is our studies
revealing the potent insulinotropic actions of glucagon in β-cells, which we have shown to be essential for
postprandial glucose control. Glucagon production in α-cells comes from the specific processing of a proglucagon
peptide by prohormone convertase 2 (PC2). Emerging literature has proposed that α-cells can differentially
process the proglucagon hormone to produce glucagon-like peptide 1 (GLP-1) through a distinct prohoromone
convertase; PC1. GLP-1 is a much more potent insulinotropic peptide, which would enhance α- to β-cell
communication and insulin secretion to a greater extent than glucagon. Our work in human subjects has
suggested that α- to β-cell communication becomes greater contributor to insulin secretion with increase
metabolic stress, raising the hypothesis that mechanisms that enhance this axis may do so a compensatory
mechanism to enhance insulin secretion in the setting of increase peripheral insulin resistance that associates
with obesity and/or type 2 diabetes (T2D). We have generated several mouse models that support this hypothesis
with strong preliminary data and propose here to move this hypothesis into a translational setting. We will utilize
preclinical studies in human islets as well as clinical studies in human subjects to test the importance of α- to β-
cell communication for insulin secretion across the metabolic spectrum and enhance our understanding of how
α-cells process proglucagon peptides to support β-cell function. This work has direct implications in the
understanding of the pathogenesis of T2D as well as the mechanisms by which incretin-based drugs control
glucose homeostasis.

Public health relevance
Project Narrative Glucagon secretion from α-cells has long been viewed as primarily a counterregulatory mechanism – e.g. an agent that with a role to prevent blood sugar from decreasing t0 levels that compromise function. Our group, along with other researchers, have begun to identify a much more complex role for α-cells, raising questions about when and how glucagon may influence blood glucose levels. This proposal looks to detail proglucagon peptide secretion from α-cells and the impact this has on β-cell function and glucose tolerance, exclusively in preclinical studies of human islets and translational studies in human subjects.